Novel bioinformatics methods for integrative detection of structural variants from long-read sequencing

Project Summary/Abstract
Structural variants (SVs) are the largest source of variations in the human genome and are frequently
associated with disease phenotypes. Thus, the identification and characterization of SVs are essential for
understanding human genome structure and function. The goal of this proposal is to develop a generalized SV
calling pipeline that can leverage information from the latest developments in sequencing technology and
human reference genome representations to discover and resolve SVs at high accuracy. I will first integrate
information across sequencing platforms to increase SV calling accuracy. Multiple sequencing and mapping
platforms are now used to detect SVs from human genome data. My pipeline will increase the accuracy of SV
calling with a data integration model that handles a diverse set of genomic platforms. I will next develop a novel
SV scoring model based on genomic context and coverage. Several factors, such as the generally low
sequence coverage in typical long-read studies, as well as alignment errors due to highly repetitive sequences,
can result in a potentially high rates of false positives for SVs when using parameters for high-sensitivity
calling. I use two sets of important features of SVs, genomic context and coverage, into a machine-learning
model to compute confidence in SV calls for downstream analysis. Finally, I will add support for graph genome
alignments by implementing support for sequence data aligned to graph genome assemblies in GFA file
format. Unlike single reference genomes, pangenomes are particularly useful for characterizing large-scale
structural differences in genomes between different ethnicity groups. Pangenomes would bring us closer to
capturing the full extent of human genomic variation, and thus represent an important resource to leverage for
SV calling. In summary, in this project I will develop a generalized SV calling pipeline capable of integrating
multiple technical platforms for discovering SVs and providing support for future developments in pangenome
graph assemblies. With the research training plan, I will 1) gain expertise in genomics and bioinformatics, 2)
promote diversity in biomedical research though involvement in educational efforts in the community, 3)
develop oral and written communication skills, and 4) prepare a scientific career focused on the study and
education of human genome variation.

Public health relevance
Project Narrative Structural variants (SVs) are frequently associated with disease phenotypes and represent the largest and most complex source of human genomic variation. Limitations in sequencing technologies lead to challenges in the accurate discovery and characterization of SVs, but which can be overcome by taking an integrative approach leveraging the advantages of multiple platforms, as well as by utilizing more comprehensive reference genome representations such as the pangenome graph. In this proposal, I will be constructing an SV calling pipeline which is versatile to technological developments across sequencing platforms, and which can leverage the latest developments in graph genome reference representations to achieve high-performance results.